Dyadic and social network influences on health and well-being among young adults with cancer

During the K01 period, I will fill critical gaps in my training through meeting five training goals: 1) enhance
knowledge in the dyadic functioning of couples with cancer with a focus on young adults (YAs) with cancer and
their partners (primary mentor: Sharon Manne, PhD, co-mentor: Katie Devine, PhD); 2) training in the
administration and analysis of qualitative dyadic data (co-mentor: Cui Yang, PhD); 3) develop specialized skills
in the assessment, analysis and interpretation of social network analysis and ecological momentary assessment
data (co-mentor: Cui Yang, PhD); 4) expertise in inflammatory stress-related biomarkers (co-mentor: Anita
Kinney, PhD); and 5) conceptual and practical knowledge in analyzing dyadic (among couples) and longitudinal
data (co-mentor: Elizabeth Handorf, PhD). These training goals and expert mentorship are designed to support
my long-term career goal of becoming an independent investigator identifying and addressing the unique needs
and experiences of young adult couples with cancer (YACs), ultimately leading to the development of evidence-
based biobehavioral interventions to address YACs unmet needs and enhance their long-term quality of life.
Cancer among YACs is a profoundly distressing experience, extracting a significant toll on YACs relationships
(e.g., with partners, family, friends). It is well recognized that effective communication within social relationships
is critical for fostering health and well-being of couples coping with cancer. Yet, only a few studies are focused
on YACs and their dyadic (couple) communication about cancer-related concerns. Even less is known about
YACs social networks and interactions within those networks that are most helpful in facilitating well-being. This
stalls the development of effective interventions aimed at improving the quality of survivorship for YA survivor
and partner. The overall goal of this K01 proposal is to fill a critical gap in the literature by focusing on YACs,
exploring their unique needs and experiences, and assessing their dyadic and social network influences on
relational, well-being, and stress-related outcomes. This will be achieved through three Specific Aims. First, to
adequately capture the YAC experience I will conduct qualitative interviews among 15 YACs to explore how
communication within their social relationships facilitates relationship satisfaction and well-being and protects
against perceived stress. Second, using social network analysis (SNA) and ecological momentary assessment
(EMA) surveys I will characterize YACs social networks and daily social interactions and communication
behaviors among 75 YACs. Finally, using SNA and EMA findings I will examine the effects of YACs social network
structure and composition, and daily dyadic and social network communication behaviors (e.g., disclosure,
responsiveness) on relationship satisfaction, well-being, and physiological responding (salivary biomarkers). My
prior training grounded in psycho-oncology, coupled with the skills and knowledge I will acquire during this award
period, will equip me to successfully conduct the proposed research and position me to continue my work focused
on fostering the long-term health and well-being of this vulnerable and understudied YAC population.

Public health relevance
PROJECT NARRATIVE Social challenges are a major issue for young adult couples coping with cancer. Impairments in their social relationships may decrease their relationship satisfaction and well-being and disrupt their physiological stress axis activity (dysregulation). This study will use innovative methods (social network analysis, ecological momentary assessment, salivary bioscience) to examine interrelationships between young adult couples’ communication, both within (couple) and outside (social network) their social relationships, and between the structure and composition of their social networks, on relationship satisfaction, well-being, and physiological biomarkers of stress among both members of the dyad to inform targeted interventions that foster the long-term health and well-being of young adult couples coping with cancer.